Data Center for Acute to Chronic Pain Biosignatures

Project Summary
Understanding the mechanisms underlying the transition to chronic pain is key to mitigating the dual epidemics
of chronic pain and opioid use in the U.S. As part of the NIH funded Acute to Chronic Pain Signatures (A2CPS)
Program, we will leverage the data collected at the Data Integration and Resource Center (DIRC) at Johns
Hopkins University and collaborating institutions. In this administrative supplement, we seek funding for an
additional two-year period to develop the career of Dr. Michael Sun toward the aim of developing neural and
inflammatory biomarkers and understand how such biomarkers predict and respond to opioid-use, as well as
their psychosocial context.

Public health relevance
Project Narrative Understanding the mechanisms underlying the transition to chronic pain is a key to mitigating the dual epidemics of chronic pain and opioid use in the U.S. As part of the NIH Common Fund Acute to Chronic Pain Signatures (A2CPS) Program. Leveraging the data accumulated at the Data Integration and Resource Center (DIRC), we will develop neural and inflammatory biomarkers, and understand how such biomarkers predict and respond to opioid-use within its psychosocial context.